Urinary Symptoms and Incontinence in Aging Reflect Loss of Lower Urinary Tract Resilience

ABSTRACT
A geroscience approach to urinary symptoms requires knowledge about the mechanisms that
normally ensure bladder control homeostasis/allostasis and how they are impacted by aging, yet
these remain largely undiscovered. My general hypothesis is that the aging bladder phenotype
is the expression of decline of multifaceted mechanisms needed to achieve adaptive control
over what the brain “knows” about bladder content. Discovering these adaptive mechanisms
and systems, and how they are impacted by aging, will address this critical knowledge gap.
In this project, I will learn and establish the technologies in my laboratory needed to discover the
neural correlates to our R01-funded investigations on the role of the HCN ion channel in
adrenergic detrusor relaxation and the impact of aging on this process. Since we have
hypothesized HCN as a mediator of neuroendocrine (sympathetic) and paracrine (mucosal)
influences over detrusor activity, we will also determine the impact of aging on mucosal and
HCN contributions to the age-increased heterogeneity of detrusor responsiveness observed in
our in-vivo and in-vitro studies. Alongside this laboratory work, I will provide clinical and
laboratory expertise with bladder control physiology to our recently formed multidisciplinary
group of expert aging researchers.
In addition to a more granular understanding of the neuroendocrine influence over bladder
volume sensing, the laboratory tools developed under this Award will contribute to new projects
focusing on the paracrine/mucosal determinants of detrusor activity, and spinal/brainstem
processes, as these mechanisms of volume sensing control provide resilience to acute (bladder
filling) and chronic (aging) challenges to control physiology. These same tools will also facilitate
our investigations of the role of a bladder phenotype in urinary dysfunctions common in age-
associated disease such as Alzheimer’s disease and other neurodegenerative conditions. The
translational research tools developed in our collaborative group will support new projects aimed
at greater understanding of the impact of aging and loss of cognitive reserve as allostatic loads
compromising asymptomatic, socially appropriate bladder control despite the acute and chronic
challenges associated with aging.
Training in laboratory techniques and aging research are incorporated into the project plan.
This training in combination with the research goals will allow me to achieve specific milestones,
moving me towards my goal of career dedication to aging bladder research.

Public health relevance
Project Narrative The experience of bladder control is the expression of resilience to multiple internal and external physiologic stressors, including aging. My research seeks to discover the contributors to resilience, and how increasing demands on declining adaptive mechanisms with aging lead to urinary symptoms and dysfunction. The goal of my research in the laboratory and with my clinical collaborators is to develop precision, geroscience-informed approaches to urinary incontinence, retention, and other bladder symptoms associate with aging.